Development of novel therapeutics to block Alzheimer's Disease progression

Project Summary
Alzheimer’s Disease (AD) afflicts over 6 million Americans, with African Americans being twice as likely as non-
Hispanic whites to develop AD. Proteomic studies of AD patient brain tissue revealed increased expression of
casein kinase 1 epsilon (CK1ε), a serine/threonine protein kinase. This overexpression of CK1ε has been shown
to be correlated with multiple pathological features of AD, including the formation of neurofibrillary tangles
(NFTs), alternation of tau protein isoform expression, and dysregulation of the circadian rhythm. NFTs are
comprised of aggregates of an insoluble form of the microtubule binding protein tau. While tau normally binds to
and stabilizes the microtubule array in neuronal axons, phosphorylation of tau leads to its dissociation and
increases the probability of NFT formation. Previous studies show that CK1ε phosphorylates tau, causing tau to
dissociate from microtubules and accumulate in the cytosol. As tau is an intrinsically disordered protein, its
cytosolic accumulation increases its propensity to aggregate – the first step in the formation of NFTs. In addition
to this direct role for CK1ε in the dissociation of tau from microtubules, there is an additional indirect role, in that
CK1ε overexpression directly correlates with the increase of an alternatively spliced form of tau that reduces the
number of microtubule binding repeats from four to three. The alteration of the ratio of tau isoforms is a hallmark
of multiple tauopathies, including AD. Finally, increased CK1ε activity causes increased phosphorylation of
period proteins (PER1/2) altering their core regulatory activity on the circadian rhythm. These findings suggest
that CK1ε is a prime candidate for therapeutic intervention to slow the progressive nature of several pathologies
associated with AD. Using computational docking studies, our research laboratory found a series of
naphthoquinones to act as dual kinase CK1δ/ε inhibitors as well as those that are selective inhibitors of CK1ε.
Structural features were identified on naphthoquinones that impart selectivity for CK1ε over its closest homolog,
CK1δ (90% to 13% inhibition for 2-chloro-5,8-dihydroxynaphthoquinone and 96% to 1% for 2-bromo-5,8
dihydroxynaphthoquinone at 10μM concentration). One of the goals of the project is to optimize our lead
compounds to increase their potency and specificity for CK1ε. We will use cellular and reconstituted biochemical
assays to determine their efficacy in blocking the CK1ε-dependent phosphorylation of tau, the alternate splicing
of the tau transcript, and the phosphorylation of period proteins.

Public health relevance
Project Narrative Alzheimer’s Disease (AD) afflicts 6.2 million Americans over the age of 65, disproportionately affecting African Americans and Hispanic populations, compared to non-Hispanic whites. The increased expression of casein kinase 1 epsilon (CK1ε) has been linked to multiple pathological features of AD, including the formation of neurofibrillary tangles and dysregulation of the circadian rhythm. This project is designed to develop and test novel therapeutics that would inhibit CK1ε and delay or prevent the onset of these corresponding AD pathologies.